Composition and Function of Membrane Contact Sites in Differentiation and Disease

ABSTRACT
Eukaryotic cells are compartmentalized into membrane-bound organelles to spatially separate incompatible
biochemical processes. However, organelles must co-ordinate their activities so that cells can respond to
changing developmental or environmental conditions. One mechanism of coordination is via membrane
contact sites (MCSs), sites of close apposition between organelles used for the exchange of ions, lipids, and
proteins. Despite being implicated in multiple metabolic and neurodegenerative diseases, the function and
composition of many MCSs is not well understood. The proposed research program will continue to explore the
function and composition of MCSs via two related themes. Because different cell types have diverse
morphologies and physiological functions, we hypothesize that organelle structure and communication must
remodel throughout differentiation of stem cells. In theme A, we will use multispectral imaging of organelles
followed up with mechanistic studies to elucidate how and why MCSs rewire during differentiation of stem cells
into neurons or skeletal muscle. This will identify common themes in organelle and MCS reorganization during
differentiation, as well as features unique to each cell type. In theme B, we will focus on lipid droplet (LD)-
organelle MCSs. LDs are lipid storage organelles with a unique structure consisting of a neutral lipid core
surrounded by a phospholipid monolayer. The unique monolayer membrane means that LDs are not
connected to vesicular trafficking pathways, so MCSs are the only way these organelles can exchange
material with other organelles. We will use spatial proteomics to identify proteins at LD contacts with other
organelles including mitochondria, the endoplasmic reticulum (ER), and the plasma membrane. We will then
test the roles of LD-organelle MCS proteins in cellular functions including lipid and protein trafficking. These
studies will yield important insights into how cells reorganize to support diverse cellular physiologies during
normal development. In addition, our work will elucidate how defects in organelle communication contribute to
conditions including metabolic, neurodevelopmental, and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Eukaryotic cells are compartmentalized into organelles that must co-ordinate their activities so that cells can respond to changing conditions. In this proposal, we will explore: (1) how organelle communication rewires to support the differentiation of stem cells into neurons or muscle cells, and (2) the composition and function of contact sites between lipid storage organelles with other organelles that synthesize or metabolize lipids. These studies will yield important insights into how cells reorganize during normal development and how organelle communication can be disrupted in metabolic or neurodegenerative disease.